Investigating siRNA-mediated inhibition of ischemia-reperfusion injury during the liver transplantation process

PROJECT SUMMARY
Liver transplantation is the only cure for liver failure, but many patients die waiting for a transplant due to a vast
shortage of donor livers. Insufficient donor supply is further diminished by ischemia-reperfusion injury (IRI) during
procurement and preservation of liver grafts. IRI-damaged grafts must be discarded because they are
dysfunctional following implantation into recipients, causing patient death. Mitigating IRI is critically needed to
increase the number of viable donor livers and improve patient survival. The IRI mechanism involves several
pathways. After ischemic insult facilitates cellular injury, reperfusion triggers oxidative stress and innate immune
pathways that converge to activate apoptosis, the major cell death mechanism in liver IRI. Hepatocyte apoptosis
in IRI is mediated by Fas receptor (Fas), and leads to necrosis and inflammation, which cause liver dysfunction.
In rats, Fas reduction prior to ischemia reduces liver damage. It may be possible to mitigate IRI-induced liver
dysfunction by silencing hepatocyte-specific Fas during the transplantation process.
The goal of this proposal is to use small interfering RNA (siRNA) to inhibit IRI and improve quality of liver grafts
for transplantation. Chemically-modified siRNAs enable potent, sequence-specific silencing of any target gene
in vivo. Modified siRNAs are delivered to hepatocytes when conjugated with N-acetylgalactosamine (GalNAc).
GalNAc-siRNA technology is the basis of numerous FDA-approved liver disease drugs. With guidance from Drs.
Anastasia Khvorova (siRNA), Paulo Martins (liver transplant), Athma Pai (RNA seq), Gyongyi Szabo (liver IRI),
Jacob Bledsoe (liver pathology), and Matthew Gounis (in vivo imaging), this project will develop in vivo and ex
vivo approaches using previously-validated GalNAc-siRNA targeting Fas to inhibit IRI and protect liver function.
Aim 1 will determine how silencing Fas prior to ischemia perturbs IRI pathways (Aim 1.1), and explore if silencing
Fas in combination with other mediators confers greater protection against liver damage (Aim 1.2). GalNAc-
siRNAs targeting Fas, alone, or in combination with validated oxidative stress (Hmgb1) and inflammation (Tnfr1)
mediators, will be injected into rats, and IRI will be induced using a liver clamp model. Post-reperfusion, target
gene expression, liver damage, and IRI transcriptome changes will be assessed. Aim 2 will determine how
silencing Fas in liver grafts (ex vivo) affects transplant outcomes in rats. Delivering siRNA during ex vivo
preservation, by either static cold storage (SCS) or machine perfusion (MP), leads to uptake into liver grafts. Rat
livers will be procured and GalNAc-siRNA targeting Fas will be delivered during SCS or MP. GalNAc-siRNA
uptake, Fas expression, and IRI transcriptome changes will be assessed over 24 hours. This experiment will
then be repeated, preserving grafts for maximal GalNAc-siRNA uptake/efficacy, transplanting grafts into rats,
and measuring liver damage/function and recipient survival. Study findings will characterize how Fas silencing
pre- and post-ischemia affects liver IRI pathways, identify in vivo and ex vivo approaches for maximal IRI
inhibition, and help develop therapies that increase the donor pool and improve patient survival.

Public health relevance
PROJECT NARRATIVE Liver transplantation is the standard treatment for end-stage liver disease; yet, many procured livers are discarded due to ischemia-reperfusion injury (IRI), perpetuating a vast donor shortage that increases waitlist times and patient mortality. This proposal seeks to utilize small RNA drugs to silence known mediators of IRI in liver grafts during the transplantation process. Findings from this study will inform the development of therapies that increase the number of viable liver grafts, saving the lives of thousands of liver disease patients.